VIRULENCE FACTORS OF COAGULASE NEGATIVE STAPHYLOCOCCI

This study seeks to determine whether coagulase negative staphylococci isolated from patients with sepsis are phenotypically different from strains considered contaminants.